Disrupting Pathways from Early Adversity to Adult Substance Abuse: Identifying Education Resilience Factors in Diverse Groups

Recent longitudinal studies suggest that well-established, adult predictors of health might actually be proxies for
health-promoting and vulnerability factors present early in life. If true, this underscores the need to identify
childhood experiences and conditions that have far-reaching effects on adult health and health behavior.
Extensive research has demonstrated the link between education and substance use problems, but to date has
provided limited understanding of underlying causal mechanisms. Some epidemiologists speculate that the
education-substance use association may be driven by unobserved, early life factors such as childhood cognitive
skills. Directly relevant to this, growing evidence from neuroscience suggests that children’s cognitive, behavioral
and socioemotional development may be profoundly impacted by early childhood adversity and “toxic stress” –
with potentially significant consequences for a child’s school experiences, educational achievement and
lifecourse health, including distal substance use outcomes. Following on the implications of this research, the
current study proposes to examine longitudinal pathways from early childhood adversity to educational and
substance use outcomes in young adulthood. Importantly, the project also aims to identify education resilience
factors from early childhood through late adolescence that can mitigate or disrupt the effects of early childhood
adversity on substance abuse. Given existing educational inequalities, racial/ethnic differences in chronic stress
and cumulative disadvantage, and disparities in adult substance use problems, the proposed study will further
investigate racial/ethnic differences in the consequences of early childhood adversity and in the protective effects
of education resilience factors. This project will entail secondary analysis of data from two ongoing national
longitudinal surveys, the Children of the U.S. National Longitudinal Survey of Youth and their mothers from the
1979 cohort of the U.S. National Longitudinal Survey of Youth. Together, they provide unusually rich, “child” data
from birth through young adulthood, linked with historical and current maternal data, and including observational
data on the home environment, and multiple perspectives on children’s schooling over time. The study is guided
by an integrative conceptual model informed by recent advances in child development, education (particularly
early childhood education), and substance use epidemiology, and is conducted by a multidisciplinary team from
the fields of public health, education, developmental psychology, sociology, and biostatistics. The study applies
innovative and state-of-the-art statistical techniques such as multi-group cross-lagged path/structural equation
modeling for reciprocal effects, and propensity score methods to test causal moderation. This research will shed
new light on lifecourse mechanisms leading to the emergence of substance use disparities, and will identify
malleable, education-related factors in different developmental periods that help to promote resilience and
reduce the harmful effects of early adversity in diverse groups.

Public health relevance
This study is a comprehensive investigation of the long-term effects of early childhood adversity on educational success and substance use outcomes from birth through young adulthood. It aims to identify modifiable, education-related factors at multiple levels (school, family, individual) that can mitigate negative effects of early adversity. Study results will help inform programmatic development and policy efforts aimed at reducing substance use problems and related health disparities.